FASEB SRC: The Gastrointestinal Tract XIX Conference: Making and Breaking a Gut

Project summary/abstract
This application requests partial support for a FASEB Scientific Research Conference entitled “Gastrointestinal
Tract XIX: Making and Breaking the Gut” that is scheduled for August 7-12, 2022 in Steamboat Springs, CO.
The meeting will convene a diverse group of speakers, including many women, underrepresented minorities
and young investigators, to discuss the biology of the gastrointestinal tract and its dysregulation in the setting
of disease. A keynote address plus eight lecture sessions will address gastrointestinal stem cell homeostasis
and plasticity in response to injury/disease, nutrition and metabolism, novel approaches using GI organoids,
the microbiota-gut-brain axis, epithelial physiology, microbial homeostasis and disease pathogenesis, mucosal
inflammation and IBD, and cancer. Ample time will be set aside for discussions amongst participants, and the
presentation of unpublished data will be prioritized. There will also be two poster sessions as well as several
career development activities for early career investigators and trainees, as well as opportunities to promote
the visibility of these individuals who represent the future of the field. We have assembled an innovative
program with committed participation from leaders with diverse expertise within GI-related research fields.
Overall, in an intimate and secluded setting that encourages informal interactions between scientists at all
levels, we provide an innovative approach to the exchange of ideas and synthesis of science that will move the
field of GI research forward. The conference will have high impact as the program spans basic science
discovery to clinical significance for GI health and disease. It is therefore expected that the meeting will provide
new insights not only into basic gastrointestinal physiology, neurobiology, developmental biology and
microbiology, but also how to treat, and ultimately cure, a wide variety of digestive disease states.

Public health relevance
Project narrative This application requests partial support for a FASEB Scientific Research Conference entitled “Gastrointestinal Tract XIX: Making and Breaking the Gut” that is scheduled for August 7-12, 2022 in Steamboat Springs, CO. The goals of this meeting are to: (1) bring together basic science, translational and clinical researchers, at all career levels, to discuss the most up-to-date scientific discoveries that pertain to the gastrointestinal system and its regulatory mechanisms; and (2) provide career development activities to enhance the professional progression of those who are new to the field. Overall, the information shared should spur the development of new understanding of, and treatments for, digestive diseases.